Development of ChromEx30 for Nanoscale Imaging of Genetic Organization and Disease Phenotypes

Project Summary
Assessing the structure of genetic material and genetic disorders at the nanoscale (~10
nm) and evaluating the 3D distribution of molecular biomarkers in that context is currently
severely limited as it depends on expensive, time-consuming and extremely complex correlative
light and electron microscopy (CLEM) as the only suitable tool. Panluminate Inc. has developed
a proprietary new cell and tissue expansion technology we call pan-Expansion Microscopy
(pan-ExM), that directly addresses this challenge. By combining ~16-fold linear expansion of
biological samples with novel bulk (pan) staining of amino acids, pan-ExM enables the
mapping of the 3D nanoscale distribution of specific biomarkers within the ultrastructure of cells.
Hallmark ultrastructural features, such as chromatin fibers and nuclear envelopes, can now be
resolved by their characteristic pan-staining pattern, analogous to heavy-metal stains in electron
microscopy (EM). In contrast to EM/CLEM, however, pan-ExM is an all-optical method that allows
researchers to interrogate biological samples using standard confocal microscopes; this offers
important advantages in terms of time, cost, complexity and sample preservation versus EM
alternatives. Our proposed Phase I project is to develop ChromEx30, a novel variant of pan-ExM
specifically tailored for genomics research that offers twice the resolution. In particular, we will:
(1) develop, optimize, and validate ChromEx30, a >30X expansion protocol for characterizing the
ultrastructure of genetic organization. We will introduce a novel polymer system that achieves
rapid >30X expansion for sub-10 nm spatial resolution imaging while retaining proteins and
maintaining isotropic 3D expansion; and (2) validate ChromEx30 as an ultrastructural phenotyping
tool at the example of Greenberg Dysplasia using control and Lamin B Receptor (LBR)
knockdown HL-60/S4 cells. This work will validate ChromEx30 as a key tool for studying genetic
disease phenotypes and lay the foundation for a Phase II project to establish it as a leading
imaging technology in genetics. Our long-term goal is for ChromEx30 to become a core
technology for creating comprehensive genomic atlases and a preferred method for targeted
research and diagnostics, advancing precision medicine across various fields.

Public health relevance
Project Narrative Nanoscale and 3D imaging of genetic material is fundamental to our understanding of genetic diseases. However, existing microscopy techniques are incapable of mapping specific biomarkers to their exact 3D location inside cells and tissue, which represents a severe obstacle in functional genomics research. We propose to develop an all-optical imaging technology that will provide researchers the ability to perform such measurements in order to better understand the ultrastructural changes associated with genetic diseases and develop better treatments.